Investigating tandem repeat expansions as a cause of schizophrenia

Tandem Repeat Expansions (TREs), most commonly of triplet repeats such as poly(CAG), are known to
underlie >30 different human neurological diseases. While the majority of TREs identified to date have been
found in late-onset neuro-degenerative disorders such as hereditary ataxias and Huntington disease, TREs
have been identified in patients with schizophrenia. In addition to expansions of short tandem repeats (those
with motif sizes between 1 and 6 base pairs), copy number variation of larger repeats with motifs ≥10bp, also
known as Variable Number of Tandem Repeats (VNTRs), has recently been linked to schizophrenia risk.
However, despite this evidence that variation in tandem repeat (TR) sequences can act as the causative
mutations in some cases of schizophrenia, there have been no concerted efforts in schizophrenia cohorts to
either systematically screen for novel TREs, or to genotype VNTR copy numbers.
Newly developed bioinformatic approaches that can be applied to analyze Whole Exome Sequencing
(WES) data now provide an opportunity to fill this knowledge gap. Utilizing the expertise and knowledge that
we have gained working on other large datasets, we propose to apply these approaches to analyze >20,000
exomes that are available to the community, and will use these data to investigate two hypotheses:
1. We hypothesize that some cases of schizophrenia are caused by rare, highly penetrant pathogenic
TREs. Using novel bioinformatic tools that can identify TREs, we will search for rare TREs that (i) using a
trio design, occur as de novo mutations in schizophrenia cases, or (ii) using a case:control design, occur
uniquely in or show significant enrichment in schizophrenia cases compared to controls, and thus are
likely causative for schizophrenia.
2. We hypothesize that common polymorphic copy number variation of VNTRs can act as genetic risk
factors for schizophrenia. We have developed a novel approach based on read depth to estimate copy
number of VNTRs from exome sequencing data. We will analyze available WES data from 6,135
unrelated schizophrenia cases and 6,245 ethnically matched controls, generating copy number estimates
for ~4,100 genic VNTRs that are represented in WES, which will be used to perform association analysis
of VNTR copy number with schizophrenia status in a case:control study.
Given that TREs, and polymorphic variation in VNTRs, both represent established mutational mechanisms that
contribute to a variety of late-onset neuro-degenerative conditions, we believe that the study of TR variation in
schizophrenia represents a logical step that has a high likelihood of uncovering novel genetic causes of
schizophrenia.

Public health relevance
Although >30 tandem repeat expansions (TREs) have been identified in a variety of late-onset neurological diseases, there have been no concerted efforts to systematically screen for novel TREs in schizophrenia cohorts. Similarly, recent studies have identified copy number variations in large tandem repeats as a risk factor for schizophrenia. Using novel bioinformatics approaches, in this proposal we will analyze exome sequencing data from >20,000 samples, including a large case:control cohort and four parent:offspring trio cohorts to identify novel TREs and large tandem repeat variants that are responsible for schizophrenia.